Uncovering Caregiver Discharge Readiness for Patient Care Transitions from Hospital to Home: The UCare Study

PROJECT SUMMARY
One in five individuals, or 53 million people, are currently acting as unpaid caregivers in the United States.
Caregivers directly contribute to patient safety and health outcomes by navigating health care systems,
managing complex care, and advocating for the needs of patients. During the high-risk process of hospital
discharge, caregiver involvement supports preparedness and continuity of care; decreased preparedness of
caregivers for discharge results in an increased risk for readmission to the hospital. CMS requires education of
patients, family, guardians, and/or caregivers about self-management, independent living, and activities of daily
living in order to be reimbursed for “care management” services, and more than 30 states have adopted the
Caregiver Advise Record Enable (CARE) Act requiring active engagement of caregivers in discharge planning
and education. However, there is no unique outcome measure available to assess how well-prepared
caregivers are to engage in caregiving activities after care recipients’ hospital discharge. Current measures of
caregivers 1) focus exclusively on general caregiver outcomes such as physical and mental wellbeing, 2) were
developed for retrospective reporting of transitional care quality vs timely application in real world clinical
settings, or 3) lack rigorous reporting of psychometric testing. Simply put, current measures don’t capture
caregivers’ specific perceptions about their own level of preparedness during the high-risk event of hospital
discharge. As a result, health systems lack a practical measure for assessing the effectiveness of discharge
preparation of caregivers, and we are left without a firm understanding of how caregiver readiness may
contribute to patients’ safe transitions home. The goal of this study is to develop and test a measure that
captures the unique factors important to caregivers’ feelings of readiness to engage in caregiving. Using a
mixed-methods approach, the specific aims of this study are to 1) develop a theoretically grounded and
psychometrically sound caregiver hospital discharge readiness scale (FamRHDS-R); 2) establish the
psychometric properties and measurement invariance of the new FamRHDS-R; and 3) establish whether and
how the new FamRHDS-R is associated with a range of caregiver and patient outcomes. The overall
hypothesis is that the new FamRHDS-R measure assessing caregiver readiness to engage in caregiving will
capture and explain variability in post-discharge patient and caregiver outcomes. Because this study is
responsive to the needs of both health systems and caregivers, and seeks to refine and test a tool based on
measures already implemented in over 35 health systems nationwide, this highly significant study is well
positioned to substantially impact hospital discharge quality and health outcomes including reduced
readmissions and overall costs of care.

Public health relevance
PROJECT NARRATIVE This study will create an assessment to better understand the readiness of unpaid caregivers to engage in caregiving activities after care recipients’ hospital discharge, and will test whether caregiver readiness is associated with patient and caregiver outcomes during their high-risk transitions from hospital to home. Results of this study will provide much needed information regarding the role of caregiver readiness in the outcomes of hospitalized patients, health systems with a way to assess the quality of discharge preparation offered to caregivers, and a means of evaluating caregiver-focused hospital discharge interventions over time and across systems.